PHASE I TRIAL OF SUBCUTANEOUS CALCITRIOL AND CARBOPLATIN IN ADVANCED SOLID TUMOR

The aims of this trial are to assess the toxicities of and determine the maximum tolerated dose (MTD) of subcutaneous calcitriol given Day 1-5 in combo with carboplatin (AUC=6) Day 5; to assess the toxicities of and determine the maximum tolerated dose (MTD) of carboplatin Day 5 when given with subcutaneous calcitriol Day 1-5 at a dose one dosage level less than the MTD; to determine the effect of administration of calcitriol on the AUC of carboplatin; and to assess the relationship between the AUC of carboplatin and myelosuppression.